Role of LAM-specific TREM1 in leukemogenesis

PROJECT SUMMARY/ABSTRACT
Cancer progression is heavily influenced by supportive cells in the tumor microenvironment. Macrophages,
an important component of tissue microenvironment, play important roles in both physiological and pathological
processes. Macrophages that infiltrate into tumor tissues are regarded as tumor-associated macrophages
(TAMs) or leukemia-associate macrophages (LAMs) in leukemia. Although a connection between LAMs and
hematologic malignancies has long been appreciated, the molecular mechanism by which LAMs promote
leukemogenesis is far less understood.
We have employed Fanconi anemia (FA), a genetic disorder associated with bone marrow failure and
progression to pre-leukemic myelodysplastic syndrome (MDS) and acute myeloid leukemia (AML), to study DNA
damage-immune responses. Using the DNA damage-induced pre-leukemic mouse model deficient for the major
FA gene Fanca (Fanca-/-) and the oncogenic MLL-AF9 AML model, we recently demonstrated that persistent
DNA damage- and oncogenic stress-induced immune receptor TREM1 (CD354) promoted leukemia progression
in mice. Compelling evidence suggests important pathological roles for TREM1 in various types of cancers,
mainly linking to its upregulation and orchestrating inflammatory responses in TAMs. However, how TREM1
functions in leukemic microenvironment remains unclear. To exploit this, we generated a conditional Trem1
mouse model, with which we deleted the Trem1 gene specifically in macrophages using the LysM-Cre deleter
strain. We found that macrophage-specific deletion of Trem1 markedly limited the expansion of Fanca-/- pre-
leukemic HSCs and MLL-AF9 leukemic stem cells (LSCs) in Fanca-/- pre-leukemic and MLL-AF9 leukemia mice.
More recently, we generated an inducible macrophage-specific Trem1-KO mouse model (Trem1fl/flCsf1r-iCre),
and found that tamoxifen induction-mediated LAM-specific deletion of Trem1 altered the gene signatures of M1
and M2 macrophages and skewed macrophage polarization toward the M1-like status in both Fanca-/- and MLL-
AF9 leukemia models. Stage-specific deletion of Trem1 significantly reduced PD-L1 expression in LAMs in these
leukemia mice. We also found that TREM1+LAMs are required for stimulating the migration and expansion of
LSCs in both Fanca-/- and MLL-AF9 leukemia models. Finally, TREM1+LAMs from AML patients were found to
promote the engraftment of leukemic cells in a patient-derived xenograft (PDX) model. These preliminary studies
establish a potential link between TREM1-positive LAMs and leukemia development. We hypothesize that
TREM1-driven interactions between leukemia-associated macrophages and leukemia stem cells
promote the development of leukemia. The goals of our study are to 1) examine the role of TREM1 within
LAMs in leukemia development and to 2) investigate the functional interplays between TREM1+LAMs and LSCs.

Public health relevance
PROJECT NARRATIVE Cancer progression is heavily influenced by supportive cells in the tumor microenvironment. The project aims to investigate the previously unknown connection between TREM1-positive leukemia-associated macrophages (LAMs) and leukemogenesis. If successfully completed, the project would uncover novel roles of TREM1 in LAM- leukemia interaction during leukemia development, and yield valuable information on whether targeting TREM1 or its signaling components may be therapeutically useful in the prevention and treatment of leukemia.